ICLIC-MS for Enhancing Outcomes Research and Clinical Care in Multiple Sclerosis

PROJECT SUMMARY
Cognitive impairment, physical disability and progressive disease are common but understudied
clinical outcomes that substantially impact employment and overall quality of life for individuals
with multiple sclerosis (MS). We have recently developed and validated an assisted, web-based
tool (ICLIC-MS) for systematic and longitudinal clinical outcomes data collection of MS-validated
cognitive function measures, physical disability and progressive disease measures that are not
reliably captured in the electronic health record (EHR). In response to FOA# PA-17-010, Use of
Technology to Enhance Patient Outcomes and Prevent Illness, our team proposes the study
of MS outcomes in a large, multi-ethnic population representative sample of more than 3,000
female and male MS cases from the Kaiser Permanente Northern California Health Plan
Membership. We will integrate other EHR data such as important comorbid conditions, use of
disease modifying therapy, MRI reports, as well as quality of life measures and employment
histories. Our goals include: 1) comprehensively characterizing clinical outcomes in a large MS
patient cohort; 2) developing and utilizing an integrated MS health report to enhance patient care;
and 3) establishing a resource for clinical outcomes research in MS that also includes whole
genomic and environmental exposure data. Findings from our proposed study represent an
extraordinary opportunity to facilitate effective long-term management of MS, accelerate progress
in the understanding of disease pathogenesis, predict patient trajectories and inform prevention
strategies. We have assembled a team with strong expertise in clinical neurology/MS neurology,
advanced epidemiologic methods, EHR structure and clinical care within a health maintenance
organization, human genomics, biostatistics, and big data approaches.

Public health relevance
PROJECT NARRATIVE Our team has developed and validated an assisted web-based interface for longitudinal clinical data collection of cognitive function measures, physical disability and depression measures that are not reliably captured in the electronic health record (EHR) of multiple sclerosis (MS) patients. We will integrate several sources of patient data including genomic, clinical and EHR for 3,000 individuals to facilitate research and improve clinical care.